Regulation of membrane trafficking by Coronins

Project Abstract
Project Summary/Abstract is included in the Scientific Justification of the Research Strategy
section.

Public health relevance
Project Narrative – from original application The subfamily of the tandem Coronins forms a structurally unique class among the extensive family of the Coronins; however, to date, their actin-regulatory functions remain completely unknown. Using a combination of single moldecule techniques, protein crystallography, and cell biology, we will investigate how the mammalian tandem Coronin, Coro7, structurally and mechanistically inhibits Arp2/3-mediated nucleation induced by nucleation promoting factors (N- WASP, WHAMM, and JMY), and other Arp2/3 regulators, including GMF, and SPIN90. In addition, we will elucidate how these actin-regulatory activities of Coro7 work in concert with Arp2/3 and its various interactors in intracellular membrane transport and autophagy. Altogether, this proposal will shed light on the enigmatic actin-regulatory functions of the class of the tandem Coronins in vitro, and in cells.